NATIONAL GENE VECTOR BIOREPOSITORY AND COORDINATING CENTER (NGVB): TASK AREA B, CORE SCIENTIFIC ACTIVITIES FOR NCI

NATIONAL GENE VECTOR BIOREPOSITORY AND COORDINATING CENTER (NGVB): TASK AREA B, CORE SCIENTIFIC ACTIVITIES FOR NCI